The UNC Core Center for Clinical Research: Phenotyping and Precision Medicine Resource Core

ABSTRACT – RESOURCE CORE
The overall goal of the UNC CCCR is to enhance the design and conduct of clinical studies in
Rheumatic and Musculoskeletal Diseases (RMDs) with a focus on osteoarthritis (OA), a
particular strength of our research community. The Phenotyping and Precision Medicine
Resource Core will provide critical services to our research community that broadly
include: 1) key scientific expertise and analytic resources needed for prognostic phenotyping
(predicting outcomes by specific subgroups, e.g. “progressors” versus “non-progressors”) and
prescriptive phenotyping (predicting response to specific interventions) using clinical datasets,
and 2) guidance and advice to investigators on phenotypic considerations (such as choice of
input and outcome variables) in order to enhance the design, implementation, and interpretation
of new clinical studies and trials. Like many chronic conditions, RMDs, including OA, are not
single diseases but rather heterogeneous conditions consisting of multiple phenotypes that
differ in their underlying pathobiological mechanisms. If not taken into consideration, these
differences result in the testing of interventions designed to address specific mechanisms of
action in the “wrong” patients. Successful treatments for RMDs therefore need to be targeted to,
and tested in, specific subgroups or subtypes that share distinct underlying pathobiological,
psychosocial and pain mechanisms, consistent with the goal of precision medicine. The
Phenotyping and Precision Medicine Resource Core will work in conjunction with the
Methodology Core to provide services that will greatly enhance study design and add
value to a wide spectrum of ongoing, completed, and planned clinical studies through
the following aims: Aim 1. Provide consultative advice and analytical services for prognostic
and prescriptive phenotyping for investigators interested in defining subgroups within new or
ongoing clinical studies in OA or other RMDs, including ancillary studies and studies in the
planning stages. Aim 2. Apply innovative strategies for phenotyping and precision medicine by
leveraging data collected in selected clinical studies from our research community, adding value
to those studies, facilitating external validation and informing future studies. Aim 3. Encourage
broader implementation of phenotyping and precision medicine approaches for RMDs through
education and dissemination of the methodologies to local, national, and international research
communities. A resource core dedicated to phenotyping and precision medicine will greatly
benefit the research community that will be supported by the CCCR, make a significant impact
on the field of clinical RMD research, and ultimately on the lives of people suffering from these
chronic and disabling conditions.